ARIC Neurocognitive Study (ARIC-NCS) Renewal 2023-2028

Abstract/Project Summary
Studies of physical and cognitive decline in persons older than 85 years are limited but suggest that late
measures of traditional risk factors have little predictive value and some inverse associations with risk.
Rigorous evidence regarding modifiable risk factors in midlife and older age could improve dementia
prevention efforts and health among the oldest old. In ARIC-NCS, with its large population and >35 years of
follow up, including the longest followed cohort of African-Americans for cognition, midlife vascular risk factors
(VRF) strongly predict dementia, frailty, physical function, and both cognitive and physical decline occurring
before age 85. Only cognitive status and physical function reliably predict dementia after 85. This raises a
compelling need to better understand risk among the oldest-old (85+ years) including deeper phenotyping to
discover markers which may explain the attenuation and distortion of risk associations at older age. The use of
blood-based biomarkers in dementia diagnosis and prediction requires assessments across the lifespan and
extension to diverse cohorts. ARIC allows exploration of differences in predictors of dementia (measured from
midlife to older age) among distinct risk groups (<85 vs 85+ years, sex, multimorbidity, and race). The
proposed fourth cycle of ARIC-NCS builds on high productivity (245 papers since 2009) to continue rigorous
data collection (proposed visits 11-13 and dementia surveillance on ~4,000 living participants ages 81-101,
~70% female and ~25% African-American; accumulating 4732 dementia cases, half over age 85 by 2028) and
address pressing questions. ARIC-NCS offers major advantages over most published studies, with over 30+
years of data in a diverse cohort starting in midlife on: (1)VRF, multimorbidity and medications; (2)behaviors
and social determinants of health (SDOH); (3)genetic, genomic, and metabolic markers; (4) longitudinal
plasma biomarker assessment; (5)quantitative brain imaging (5438 MRIs and 1146 amyloid PET; an additional
~400 of each expected in 2023); and (6)clinical outcomes, to which we will collect additional measurement of
multimorbidity, repeated biomarkers, cognitive and physical function, sleep and activity. ARIC-NCS can control
for an extensive range of covariates and modifiers, and we will consider race- and sex-specific analyses. The
specific aims are: 1) Longitudinally study blood biomarkers (~5000 proteins and targeted blood AD
biomarkers (amyloid, p-tau, NfL and GFAP) across 4 decades) in relation to: (i) dementia; (ii) mild cognitive
impairment; (iii) multimorbidity and frailty; (iv) cognitive and physical function (e.g. short physical function
battery, gait speed) decline. 2) To evaluate the association and interaction of midlife VRF, multimorbidity
(including disturbed sleep), and SDOH with blood (proteomic and targeted AD and neurodegeneration
markers) and brain imaging (MRI & amyloid PET) dementia biomarkers and their progression. 3) Contrast
associations of vascular risk factors, cognitive and physical function and multimorbidity with dementia,
cognitive and physical decline across ages (65-84 vs. 85+) and their modification by health at older age.

Public health relevance
Narrative The ARIC neurocognitive cohort will now answer the compelling need to better understand risk of Alzheimer's dementia and Alzheimer's related dementias (AD/ADRD) among the oldest-old (85+ years) where current risk factors are not predictive. ARIC takes a comprehensive approach by studying a large diverse group of people from middle age to the oldest age with over three decades of rigorous data collection on every aspect of their lives. This renewal builds on very high productivity (245 papers since 2009) to continue rigorous data collection (proposed visits 11-13 accumulating 4732 dementia cases, half over age 85 by 2028) with a focus on blood biomarkers and outcomes across every aspect of aging.